Exploiting immunostimulatory microbial pattern recognition to improve head and neck cancer therapy

PROJECT SUMMARY
The prognosis of patients with advanced head and neck squamous cell carcinoma (HNSCC), including oral
cancer, remains poor. Radiation therapy (RT) is widely used for clinical management; however, recurrence
occurs frequently in patients with advanced diseases. While the rich immune infiltrate often seen within these
tumors designates them as prime candidates for immunotherapy such as immune checkpoint inhibitors (ICIs),
the response rates in patients with recurrent, metastatic disease is low, indicating an unmet clinical need for
developing novel approaches to improve outcomes. In this application, we propose to address these challenges
using a novel immune PRIME agent (i.e., Flagrp170), in which a unique microbial pattern recognition sequence
is built into a superior antigen-delivery platform, to immunologically program the tumor microenvironment to
enhance HNSCC responsiveness to standard of care (i.e., RT, ICIs). This first-in-class multi-functional agent
possesses distinct features for optimizing and sustaining immune activation (e.g., forcing cancer cells to produce
and secrete a foreign molecule carrying tumor antigenic fingerprints, thereby revitalizing the function of antigen-
presenting cells) while concurrently reversing tumor-induced immunosuppression. We will investigate a newly
engineered human version of this agent therapeutically and mechanistically to support its bench-to-bedside
translation. To accomplish our goal, we will evaluate the immunotherapeutic activity of hFlagrp170 administered
intratumorally using multiple oral cancer models and investigate its mechanism of action in orchestrating innate
and adaptive antitumor immunity. We will study the interplay between cancer cells and the immune system
governed by this microbial chimeric molecule and a less studied microbial pattern recognition signaling pathway.
To prevent the tumor recurrence that is often associated with advanced HNSCC following RT, we will leverage
the unique property of hFlagrp170 to promote the immunogenicity of cancer cell death and transform the immune
landscape of irradiated HNSCC to amplify the ‘abscopal’ response of RT. Additionally, we will use hFlagrp170
to potentiate HNSCC susceptibility to ICIs by increasing tumor-reactive T-cell repertoire and provide mechanistic
insights into the hFlagrp170-induced T-cell ‘inflamed’ tumor phenotype. Since an RT and ICI combination
regimen being tested extensively in the ongoing trials has yet to show clinical benefits, we will evaluate a tripartite
anti-HNSCC approach by capitalizing on the superior immune programming activity of hFlagrp170 to achieve a
robust and durable antitumor response. The successful completion of this project is anticipated to establish a
scientific framework for rapid translation of this immune PRIME agent, which not only will expand the toolbox of
Immuno-Oncology, but also can potentially revolutionize the current treatments of advanced HNSCC.

Public health relevance
PROJECT NARRATIVE Current management of head and neck cancer including radiation therapy or immunotherapy has not significantly improved the overall survival of patients with advanced HNSCC. This application aims to test a novel molecular platform with a built-in microbial sequence that can potentially achieve robust and long-lasting antitumor immunity to enhance cure rates by overcoming the therapeutic barriers in the tumor microenvironment.